KUH-ART: Advanced Research Training in Kidney disease, Urology and Hematology

Overall Abstract
Under a multi-PI leadership with an established track record of scientific and mentorship collaboration, we
propose a comprehensive Los Angeles metropolitan area-based interdisciplinary graduate and postgraduate
training program (KUH-Advanced Research Training or KUH-ART). The overarching objective of this program
is to prepare trainees for long-term productive careers in high-impact research in benign nephrology, urology
and hematology. To achieve this goal, we will:
1) Recruit outstanding and diverse pre- and postdoctoral students. We will reach out through multiple
media and programs to students and trainees at all levels, nationwide, and through fellowship matching
programs in the KUH area, highlighting the attractive opportunities in the KUH-ART research space
2) Develop and support a personalized guidance program, matching interested trainees with research
mentors and labs. We will provide (a) easy-to-access general mentoring support and trainee advocacy, (b)
career guidance and general research career skills (manuscript and grant preparation, collaboration, scientific
communication, and networking) through partnerships with existing programs under UCLA-CTSI, and (c)
trainee exposure to the array of available research careers from academia to biotechnology and pharma.
3) Incentivize the development and support of specific educational research-oriented KUH content for
KUH trainees at all levels, leveraging existing seminar series, courses and conferences. We will
construct and evolve a virtual learning environment (VLE) that facilitates formal and informal interactions
among our trainees, with mentors, and with trainees at other similar programs. We will develop new
instructional content specific to the needs of our trainees. We will facilitate the participation of KUH trainees
in broader scholarly communities according to their level of training (MSTP, graduate student lecture series
and seminars, CTSI KL2 courses), and introduce KUH content into these activities.
4) Measure and evaluate quality and outcomes to assess program effectiveness. Guided by our external
and internal advisory boards, we will use the evaluation process for continuous quality improvement in
curricular offerings, the learning environment, and trainee outcomes.
KUH-ART will benefit from strong institutional support that will allow us to integrate existing resources and
consolidate productive interinstitutional relationships. The geographic footprint and infrastructure of KUH-ART
will build on the highly successful UCLA Clinical and Translational Science Institute, a research partnership of
leading local institutions: UCLA, Cedars-Sinai Medical Center, Charles R. Drew University of Medicine and
Science and Harbor-UCLA Medical Center/Lundquist Institute for Biomedical Innovation. Successful
implementation of KUH-ART will assure that diverse and talented biomedical trainees in the Los Angeles
metropolitan area are recruited and optimally trained to contribute to solving important problems in the KUH area.

Public health relevance
Narrative Under a multi-PI leadership with a strong track record of scientific and mentorship collaboration, we propose a comprehensive regional interdisciplinary graduate and postgraduate training program (Kidney, Urologic, and Hematologic-Advanced Research Training or KUH-ART) to prepare trainees for long-term productive careers in advanced research in benign nephrology, urology and hematology. The overarching goal of the program is to recruit outstanding KUH trainees from diverse backgrounds and prepare them to lead multidisciplinary teams that produce KUH research with high impact on medical science and clinical outcomes. We benefit from exceptional resources: 1) our location one of the most creative and diverse metropolitan areas in the world, 2) UCLA, the top public University and its affiliates, and 3) relationships to elite research institutions including Caltech and RAND.